Adaptable tissue-specific endothelial cells for organ regeneration

PROJECT ABSTRACT
The overarching goal of our proposed research program is to develop a discovery pipeline that will enable
identification of transcriptional codes for engineering tissue-specific endothelial cells (ECs) for therapeutic
organ regeneration of heart, lung and blood. Therapies for organ regeneration promises unlimited access to
the replacement tissues. However, despite breakthroughs in uncovering the molecular underpinnings of organ
morphogenesis and organoid technology, translation of regenerative medicine to the clinic has confronted with
hurdles. These bottlenecks are in part due to the lack of understanding as to how niche cells coordinate organ
repair. Specifically, contribution of vascular niche cells that supply regenerative signals has not been realized.
This R35 application builds upon the novel proposition that poor healing after organ damage is due to the
dysfunction and loss of the tissue-specific ECs. This programmatic proposal examines the hypothesis that
reconstitution of stem cells in injured organs is dependent on the pro-regenerative angiocrine signals supplied
by tissue-specific vascular niche ECs. We have shown that organotypic ECs by deploying defined angiocrine
factors support lung, cardiac, hepatic and hematopoietic regeneration. Thus, ECs perform actively as dynamic,
tissue-specified niche cells critical for tissue homeostasis and repair. To test this and to set up the stage for
therapies, we have engineered adaptable mouse, nonhuman primate and human ECs by transducing the
transduction factor (TF) ETV2 into adult mature ECs (R-VECs) and differentiating human induced pluripotent
stem cells (iPSCs) into generic fetal-like ECs (iVECs) that could inform on the pathways that induce
organotypic TFs. These adaptive iVECs and R-VECs will be cocultured with heart, lung, and blood organoids
in vitro or infused in vivo in mice undergoing organ repair to identify the induction of organotypic TFs in these
cells. The educated iVECs and R-VECs will be recovered and subjected to RNA profiling and de novo motif
discovery to identify induced tissue-specific TF(s). The identified TFs will be overexpressed or knocked down
in ECs, to validate their function in sustaining organotypic and angiocrine profile for organ repair. We anticipate
that transplantation of organotypic ECs will promote long-lasting tissue repair without provoking tumorigenesis
or fibrosis. We have initiated FDA-approved human clinical trials to examine the safety and efficacy of
allogeneic generic EC infusion for hematopoietic recovery. As a follow up, we intend to assess the contribution
of R-VECs or iVECs-derived from nonhuman primates to regeneration in the pigtail macaque monkeys with the
intention of translating the potential of organotypic ECs to clinic. The expected outcomes of the proposed
research are identification of molecular signals and transcriptional determinants of tissue-specific vascular and
angiocrine heterogeneity. Goals of this proposal fit with the mission of NHLBI R35 award to develop innovative
regenerative discovery pipeline to promote safe and efficacious treatments for cardiac, pulmonary and blood
maladies.

Public health relevance
Project Narrative Current approaches for treatment of organ injury has focused on the delivery of growth factors or stem cells without any major benefit, in which fibrotic scarring interfere with functional integrity of the damaged organs. We have shown that specialized endothelial cells lining the blood vessels in each organ by production of unique growth factors could support organ repair without provoking fibrosis or tumorigenesis. To translate the potential of endothelial cells for regenerative medicine to clinic, we have proposed experiments to understand how endothelial cells acquire organ-specific functions to optimize their efficacy in regeneration, with the intention of transplantation these tissue-specified ECs to augment the repair of lung, blood and broken hearts without scarring.